Validation of a Disease-Specific Instrument for Pediatric Inherited Neuropathy

DESCRIPTION (provided by applicant): Charcot-Marie-Tooth disease (CMT), or inherited motor-sensory neuropathy, afflicts 1 in 2500 children, often resulting in pain, depression, disabling weakness and significantly reduced health-related quality of life (QOL) by adulthood. Reducing this large disease burden by treating children who are in the early stages of the disease is crucial; however, to date, no therapy has proven effective in clinical trials. The lack of treatment effect in recent trials may have been due to the selection of unsuitable outcome measures. The current lack of valid, sensitive and reliable primary outcome measures to utilize as endpoints in pediatric inherited neuropathy trials represents a critical barrier to progression in this field. The research objective of this application is to identify an outcome measure that accurately reflects CMT disease progression in children. The central hypothesis is that a disease-specific pediatric CMT QOL instrument will serve as a valid, reliable, and more sensitive measure of disease progression, than previously utilized neuropathy trial endpoints. The rationale for the proposed research is that identifying validated outcome measures for a clinical trial increases the likelihood that potentially efficacious therapies are not discarded injudiciously. The specific aims of the project are to (a) identify the QOL instrument of greater clinical validity between generic and disease-specific options in pediatric CMT, and (b) identify the outcome measure that is most relevant to the pediatric patient with CMT, among composite neuropathy scores, electrophysiology, and QOL data, through a prospective, multicenter longitudinal clinical trial in 400 children with CMT. This proposal is significant because it would identify valid, sensitive and reliable outcome measures that could (a) serve as endpoints in planned clinical trials of interventions designed to improve the quality of life of this population, and (b) assist in monitoring the perspective of a highly vulnerable population: children with disability due to a chronic, progressive neuromuscular disease. The study is potentially innovative, because it may lead to the selection of patient- reported outcomes as primary endpoints in neuropathy trials, thus shifting the current paradigm of utilizing electrophysiologic outcome measures, which have rarely shown meaningful improvement in clinical trials. The proposed research is relevant to the NIH's mission to help reduce the burdens of human disability, as achieving study aims will positively impact future efforts to identify therapeutic interventions that improve the QOL of patients with neuromuscular diseases. Dr. Ramchandren's long-term goal is to develop interventions that result in improved QOL for patients with neuromuscular diseases, and develop expertise in the application of outcome measures in clinical trials. The PI is uniquely well-positioned to achieve her goals at Wayne State University under the primary mentorship of Dr. Michael Shy, who has extensive expertise in CMT genotypic- phenotypic correlations, and who also has expertise in evaluating the reliability and validity of outcome measures for clinical trials. The mentored career development award provides the ideal medium for the PI to become an independent neuromuscular researcher and authority on outcome measure utilization in clinical trials. The PI's career development will be facilitated by: (1) an expert multidisciplinary mentorship team, (2) didactic graduate lectures and workshops in Survey Methodology, which will expand on the PI's previously acquired Master of Science in Clinical Research Design and Statistical Analysis and (3) direct access to the resources of the NINDS-funded Inherited Neuropathy Consortium directed by the PI's mentor, which is designed specifically to conduct and promote clinical research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Identification of validated outcome measures for pediatric inherited neuropathy trials offers the opportunity to develop targeted therapies that may eventually be broadly applicable to all neuropathies. Thus, study outcomes will positively impact future efforts to improve the quality of life of patients with neuromuscular diseases. The proposed research has relevance to public health, because enabling researchers to measure treatment responses in children with inherited neuropathy via reliable, valid and sensitive outcome measures can lead to interventions that help reduce the disease burden in this vulnerable population. Identification of validated outcome measures for pediatric inherited neuropathy trials offers the opportunity to develop targeted therapies that may eventually be broadly applicable to all neuropathies. Thus, study outcomes will positively impact future efforts to improve the quality of life of patients with neuromuscular diseases. The proposed research has relevance to public health, because enabling researchers to measure treatment responses in children with inherited neuropathy via reliable, valid and sensitive outcome measures can lead to interventions that help reduce the disease burden in this vulnerable population. __SpecificAimsTextDelimiter__ 2. STATEMENT OF HYPOTHESIS AND SPECIFIC AIMS Charcot-Marie-Tooth disease (CMT), or inherited motor-sensory neuropathy, afflicts 1 in 2500 children, often resulting in pain, depression, disabling weakness and significantly reduced health-related quality of life (QOL) by adulthood. Reducing or reversing this large disease burden by treating these children who are in the early stages of the disease is, therefore, crucial. Promising results from animal studies for CMT have led to several clinical intervention trials; however, to date, no therapy has proven effective. The lack of a significant treatment effect in these trials may have been due to the selection of slow-changing electrophysiologic measurements as the primary outcome measure. Our own preliminary studies indicate that a disease-specific QOL instrument may be a better outcome measure for this patient population. Our NINDS-funded Inherited Neuropathy Consortium (1U54-NS065712-01) is leading efforts to conduct additional clinical trials in pediatric inherited neuropathy through national and international collaborations. Nevertheless, the current lack of valid, sensitive and reliable primary outcome measures to utilize as endpoints in these trials is a critical barrier to progression in this field. My long-term goal is to develop interventions that result in improved QOL for patients with neuromuscular diseases, and to develop expertise in the application of outcome measures in clinical trials. The research objective of this K23 application, which is the next step in pursuit of that goal, is to identify an outcome measure that accurately reflects CMT disease progression in children, among composite neuropathy scores, electrophysiology and QOL data, while validating a disease-specific pediatric CMT QOL instrument developed in collaboration with the NINDS-funded Quality of Life in Neurological Disorders (Neuro-QOL) investigators. Based on my preliminary studies, my central hypothesis is that a disease- specific pediatric CMT QOL instrument will serve as a valid, reliable, and more sensitive measure of disease progression, than previously utilized neuropathy trial endpoints. The rationale for the proposed research is that identifying validated outcome measures for a clinical trial increases the likelihood that potentially efficacious therapies are not discarded injudiciously. I am uniquely well-positioned to achieve my goals at Wayne State University under the primary mentorship of Dr. Michael Shy, who has extensive expertise in CMT genotypic-phenotypic correlations, and who also has expertise in evaluating the reliability and validity of outcome measures for clinical trials. I will test my hypothesis through a prospective, multicenter longitudinal clinical trial in 400 children with CMT, utilizing the considerable pooled resources of our Inherited Neuropathy Consortium (PI- Dr. Shy; see Facilities and Other Resources). My educational goal is to expand on my previously acquired Master of Science in Clinical Research Design and Statistical Analysis by completing graduate coursework in survey methodology, and advanced statistical analysis workshops in item response theory and Rasch methodology, a crucial step in achieving independence in the utilization of outcome measures for clinical trials. By aligning the aims of my proposal with those of the Inherited Neuropathy Consortium, I expect to successfully accomplish my research objective, and obtain practical experience with multi-center clinical trials. I propose the following specific aims: Specific Aim # 1: Identify the QOL instrument of greater clinical validity between generic and disease-specific options, in pediatric CMT. Hypothesis: A disease-specific QOL instrument will serve as a reliable and more valid measure of disease burden than a generic instrument, in pediatric CMT. Specific Aim # 2: Identify the outcome measure that is most relevant to the pediatric patient with CMT, among composite neuropathy scores, electrophysiology and QOL data. Hypothesis: A disease-specific QOL instrument will best predict patient-perceived longitudinal changes in clinical function, in pediatric CMT. This project is designed to directly address the lack of valid, sensitive and reliable primary outcome measures in pediatric inherited neuropathy. It is potentially innovative, because it may lead to the selection of patient-reported outcomes as primary endpoints in neuropathy trials, thus shifting the current paradigm of utilizing electrophysiologic outcome measures, which have rarely shown meaningful improvement in clinical trials. Our success in achieving the proposed study outcome would lead to the identification of validated outcome measures for future independent R01 applications for clinical trials in patients with inherited neuropathies. The research objective outlined in this proposal will thus positively impact future efforts to identify therapeutic interventions that improve the QOL of patients with neuromuscular diseases.